Overcoming mechanisms of PTPN1 driving therapy- and castration- resistant prostate cancer with novel theranostics

Project Summary/Abstract
Overwhelming data from clinical experience clearly indicate that the recurrent therapy- and
castration-resistant prostate cancer (t-CRPC) is responsible for the majority of these deaths
because these cells exhibit resistant phenotype to hormonal therapy as well as conventional
chemotherapy. Thus, new therapeutic target(s) based on molecular mechanisms leading to
resistant phenotype is urgently needed for prolong the survival of prostate cancer (PCa) patients.
More than 25% of the metastatic CRPC patients on highly potent new-generation anti-androgen
therapies end up with neuroendocrine prostate cancer (NEPC). Currently, NEPC is considered
as an end stage disease because only few chemotherapeutics for NEPC with unsatisfied
outcome. From several tissue culture and transgenic animal models, data suggest that hormonal
therapy promotes androgen-dependent prostate adenocarcinoma (ADPC) cells to undergo
transdifferentiation then become therapy resistant NEPC. Nevertheless, the underlying molecular
mechanism remain largely uncharacterized. In this study, we provide strong evidence that the
protein tyrosine phosphatase non-receptor 1 (PTPN1) plays a critical role in PCa
transdifferentiation. For example, Increased PTPN1 expression in ADPC promotes the onset of
NEPC. In contrast, knocking down PTPN1 expression in NEPC cells can restore ADPC
phenotype. Thus, this project is to examine the regulation of PTPN1 gene expression by anti-
androgens and unveil the reciprocal regulatory network among PTPN1-androgen receptor- RE1-
silencing transcriptional factor then identify the downstream effector(s) of PTPN1 in promoting
NEPC. Most importantly, it is to develop a new NEPC-specific theranostic strategy by engineering
NEPC-specific small drug conjugate with molecular imaging capabilities. The ultimate goal is to
explore clinical translation by formulating a new therapeutic regimen with PTPN1 theranostics
and anti-androgen agent in clinically relevant animal models. The outcome gained from this
project will revolutionize the current concept of recurrent t-CRPC therapy in order to improve
overall survival of patients.

Public health relevance
Project Narrative We will unveil the driver mechanism of transdifferentiation of prostate cancer (PCa) leading to the appearance of neuroendocrine (NE) phenotypes, which can contribute to the onset of therapy- and castration-resistant PCa (t-CRPC). The goal is to develop new specific targeting strategies for t-CRPC based on the identification of the key regulator in NE PCa development. Overall, this outcome of this experimental therapy study using clinically relevant models is expected to have significant impact on personalized medicine for incurable and lethal PCa.